Addition of a Reverse Amide to Methacrylate-Based Dental Materials to Inhibit Microbial Biofilm Formation.

Secondary caries (SC), the leading reason for the repair or replacement of bonded resin composite fillings
worldwide across both pediatric and adult populations, mirrors the etiopathogenesis of primary caries, originating
from stagnant Streptococcus mutans biofilms on filling surfaces. For many decades, research efforts on SC
prevention have predominantly concentrated on integrating antimicrobial agents into methacrylate-based dental
materials (MBM), employing synthetic or natural molecules as well as heavy metal elements. The therapeutic
mode of action of these agents, rooted in bacteria-killing mechanisms via surface contact with dental materials
and/or drug release, has the potential to disrupt the delicate ecological balance (eubiosis) between commensal
(beneficial) and pathogenic (harmful) bacteria within stagnant biofilms, potentially exacerbating dental plaque
activity instead of preventing it. Consequently, dentistry faces a shortfall in materials capable of inhibiting
disease-associated biofilms while preserving commensal species. Our overarching objective is to leverage the
antibacterial properties inherent in the reverse amide 2-aminoimidazole (RA/2-AI) family of small molecules to
engineer innovative dental materials. Research findings results have indicated that they covalently interacted
with methacrylate and inhibited S. mutans biofilm formation while promoting commensal species when used in
water-based solutions. The overall objectives of this NIH grant application are to (i) synthetize a derivative of the
RA/2AI family, i.e. 2-amino-N-undecyl-H-imidazole-5-butanamide, hereafter H10, as well as use click chemistry
to generate a new methacrylate-based antimicrobial agent containing covalently conjugated H10-HEMA
monomer, (ii) formulate MBM self-etch adhesive (SEA) containing both forms of H10, and evaluate their
biostability, mechanical characteristics, tooth-material bond strength, and (iii) assess their effectiveness against
dysbiotic dental biofilm. The central hypothesis is that MBM-SEA containing H10 sustain mechanical and tooth
adhesive properties while inhibiting dysbiotic Streptococcus mutans biofilm formation. The rationale for this
project lies in the comprehensive assessment of the biostability, mechanical robustness, tooth-adhesive
characteristics, and biofilm inhibition capabilities inherent in SEA containing H10 synthetized forms. The following
specific aims are proposed: 1) Evaluate the biostability, mechanical and tooth-material bond strength properties
for H10 SEA forms; and 2) Determine in vitro effectiveness SEA against dysbiotic dental biofilm. Under the first
aim, HPLC will evaluate H10 release, three-point bending the flexural strength, microtensile bond strength will
examine the materials' short- and long-term dentin-enamel adhesion. The research proposed in this application
is innovative because 1) it focuses on 2-AI small molecules that inhibits and/or disperse S mutans biofilm, and
2) is amendable to covalent conjugation via click-chemistry with methacrylate-based monomers. The significance
of this work lies in its potential to advance dental materials that effectively combat biofilm dysbiosis associated
with cavities at the margins of MBM fillings.

Public health relevance
Project Narrative The proposed research holds significant relevance in the realm of public health as it centers on the advancement of methacrylate dental materials (MBM) incorporating reverse-amide 2-aminoimidazole (RA/2-AI) small molecules, which exhibit potent inhibition against dysbiotic Streptococcus mutans biofilm—a key contributor to secondary caries (SC) formation along the margins of MBM. The development of such experimental materials presents a promising opportunity to address the vulnerability inherent in current MBM formulations (dental adhesives, resin composites, resin modified glass ionomers), potentially curbing the occurrence of SC. By bolstering the defensive capabilities of these materials, the research aligns closely with the mission of the National Institutes of Health (NIH) to pursue foundational insights and breakthroughs in dental biomaterials, ultimately contributing to the broader improvement of global population health.